Chemical Exchange Weighted Molecular MRI: Technical Development and Clinical Translation

TR&D1: Chemical Exchange Weighted Molecular MRI: Technical Development and Clinical Translation
Project PI: Ravinder Reddy, PhD
Abstract
This TR&D project focuses on metabolite weighted CEST MRI technologies for spatially resolved imaging of
several key metabolites (glutamate, myoinositol, creatine and lactate) that serve as biomarkers of a variety of
disease processes. To this end, it develops novel technologies including (i) deep learning approaches for B1 and
B0 correction of CEST images of different metabolites (ii) volumetric acquisition methods for improved spatial
resolution of the CEST weighted imaging of different metabolites and (iii) technologies for dynamic studies of
exercise mediated OXPHOS measurements in skeletal muscle, and (iv) CrCEST acquisition methods for
measuring the metabolic activity of human myocardium. These technologies are driven by 7 collaborations and
serve 8 service projects from within PENN and from other institutions distributed across the US. Successful
completion of the goals will lead to technologies that will have sustained impact on the field of biomedicine
through their contribution to the understanding of pathophysiological underpinnings of several disorders, and
through the use of these technologies as biomarkers for diagnosis and evaluation of therapeutic responses of
existing and novel therapies that constitute precision medicine strategies for patient care. In addition,
dissemination of these technologies to collaborators from PENN and institutions across the country and abroad,
and training of next generation of biomedical scientist and physician scientists, and potential opportunities for
commercialization of the technologies will have immense national impact.